Career Enhancement Program

PROJECT SUMMARY
The goal of the DF/HCC SPORE in Prostate Cancer Career Enhancement Program (CEP) is to provide resources, financial support, and mentorship for faculty who are transitioning or have recently transitioned to independent positions (Instructor or Assistant Professor). The overarching goal of the SPORE CEP is to attract and nurture investigators as they develop careers translational prostate cancer research in clinical, basic, and population science. In turn, the DF/HCC Prostate SPORE program as a whole will greatly benefit through interactions with fresh ideas and talent. Applications for at least two annual CEP awards will be solicited broadly across DF/HCC and Massachusetts and will undergo a fair and transparent review process overseen by CEP leadership (Drs. Paul Nguyen, Lorelei Mucci, and Adam Feldman). Request for Applications will be announced by e-mail and social media, posted throughout the DF/HCC institutions via message boards and featured on the DF/HCC, Prostate SPORE and Harvard Catalyst websites, and outreach by CEP leaders. The CEP program will help advance the research careers of faculty by providing funding for independent projects, infrastructure and resources through the cores, interactions with established prostate cancer investigators through SPORE meetings and educational sessions, and by establishing a formalized mentorship program. The CEP program will build upon a strong prior track record of success in enhancing and supporting career development, and is a critical piece of the overall DF/HCC Prostate SPORE program in our mission to train and develop the next generation of leaders in prostate cancer translational research.

Public health relevance
PROJECT NARRATIVE The mission of the DF/HCC SPORE in Prostate Cancer Career Enhancement Program (CEP) program is to train, support, and develop early-career faculty as they become leaders in prostate cancer translational research. This will be achieved through financial support for independent projects, resources through the SPORE cores, exposure and interactions with investigators through SPORE activities, and a formal mentoring program.